The role of SARS-CoV-2-induced senescence in the development of Alzheimer's Disease

Project Summary/Abstract
SARS-CoV-2 has been associated with neurological symptoms, although there is no strong evidence of a direct
viral infection in the brain. Recent reports indicate that SARS-CoV-2-induced systemic inflammation and the
cleaved S1 subunit of the S protein remain detectable in patients with COVID-19 for months after diagnosis and
may cause neurological manifestations. Also, COVID-19 tends to be more severe in older people, and although
various biological responses change with aging, the induction of cellular senescence (SC) is predominant. New
findings indicate that SARS-CoV-2 induces senescence in the lung epithelium with an exacerbated senescence-
associated secretory phenotype (SASP) in response to the S1 subunit of the SARS-CoV-2 spike protein. Here,
we will investigate how SARS-CoV-2 promotes CS in the brain and the role of SASP components in conveying
senescence and promoting AD pathogenesis. Our preliminary data show that the S1 protein enters the systemic
circulation and accumulates in the choroid plexus (CP) epithelium that expresses the ACE2 receptor. When S1
is combined with systemic inflammation, it induces a senescence-like phenotype in the brain of aged mice,
initially restricted to epithelial cells in the CP, but it spreads to other brain regions, including the cortex and
hippocampus, within a month. Transcriptome analysis in the brains of aged S1-challenged mice with systemic
inflammation 30 days post S1 administration identified the "metabolic pathways," "pathways in
neurodegeneration," and "Alzheimer's disease" among the top 10 enriched pathways. We also investigated how
the S1 cleaved subunit induces cellular senescence (CS) in the choroid plexus epithelial cells when combined
with systemic inflammation, and our results indicate that S1 induces dysfunction of the Nrf2-antioxidant
response, which leads to accelerated CS when it is accompanied by LPS-induced ROS production. Most
importantly, SASP analysis revealed the role of soluble factors SASP and EV-miRNA SASP components in
conveying CS of neurons and regulating CS and AD pathways, respectively. Therefore, our goal is to explore
whether miRNA replacement therapy can abrogate secondary SASP-induced senescence and AD pathogenesis
and progression. Furthermore, analysis of postmortem brain sections and CSF from AD patients revealed the
presence of CS markers in the CP long before the robust accumulation of β-amyloid and tau tangles in HPC,
suggesting that CS may play an important role in Alzheimer's pathogenesis. Analysis of CSF from the early
stages of AD also showed high levels of soluble SASP factors, which correlates well with the cellular senescent
burden in the CP that produces the CSF. These findings prompted us to examine the relationship between CS
and SARS-CoV-2 infection further and how it may increase the risk for AD. Our hypothesis is that SARS-CoV-
2-induced SASP in the CSF induces neuronal senescence and increases AD risk. Patients with severe COVID-
19 may be predisposed to develop AD later in life. These studies will allow us to identify better diagnostic markers
and therapeutic targets and enable early intervention to prevent the development and progression of AD.

Public health relevance
Project Narrative Patients with severe COVID-19 could be predisposed to develop Alzheimer’s Disease (AD) later in life. We aim to investigate the mechanisms by which SARS-CoV-2-induced cellular senescence may contribute to the pathogenesis of AD. The proposed research findings will allow us to understand how cellular senescence spreads and its role in AD pathogenesis, paving the way for identifying new interventions to prevent or slow down AD progression.